Diversity in Practice: the Quest for Inclusion in Precision Medicine

PROJECT SUMMARY/ABSTRACT
Broad recognition of a diversity gap in genomic datasets has fueled calls for targeted recruitment and retention
of individuals from populations that have historically not participated in biomedical research. Yet, definitions of
what constitutes diversity, according to whom, and how best to implement goals of inclusion remain elusive.
Precision medicine research (PMR) is a significant and consequential sphere of scientific inquiry where
questions about the meanings and effects of diversity are being worked out in practice and increasingly
institutionalized. Approaches to increasing diversity and inclusion of racial and ethnic minority populations in
precision medicine research are heterogeneous, but little is known about their impact. To fill this gap, we have
embarked on three studies that empirically examine different stakeholder perspectives and experiences with
PMR and its varied approaches to enhancing diversity and inclusion of underrepresented populations as
research participants. This project will synthesize data and findings from across these studies, to develop what
will be the first book-length analysis of diversity in practice in PMR, and its consequences for meaningful
inclusion. The specific aim of this grant application is to complete a book manuscript that will examine the
ethical and social dimensions of concepts of diversity and inclusion, how they are put into practice by
stakeholders in precision medicine research, and their impacts for our understandings of health and human
variation. The data to be included in this book come from three NIH-funded studies led by the co-authors that
include focus groups with racially and ethnically diverse patients to assess their attitudes towards the use and
governance of clinical data and samples; a review of documents related to three NIH-funded PMR consortia
and 5 PMR research sites; observations of PMR consortia and site activities; and in-depth interviews with PMR
funders, researchers, participants, and individuals from diverse populations being recruited for PMR. Such a
book will offer an empirically informed, ethnographically rich analysis and reflection on how PMR diversity
practices are unfolding, and with what consequences for the populations it seeks to serve and for the larger
society in which it is embedded and helps to shape. The target audiences for this book include: researchers
who conduct genomics and precision medicine research, policymakers and research funders, research
institutions and research staff, commercial entities involved in biomedical research, scholars in bioethics,
sociology and anthropology, science and technology studies, and health policy, and members of the general
public with interests in health, genetics, and biomedical research.

Public health relevance
PROJECT NARRATIVE This project aims to develop a book manuscript that synthesizes findings from three NIH-funded studies and over a decade of empirical research on stakeholder perspectives on approaches to achieving diversity and inclusion in precision medicine research. By examining how stakeholders understand and implement concepts of diversity and inclusion in precision medicine research, this book will provide key empirical insights on the consequences of diversity and inclusion practices for our understandings of health and human variation. It will also help inform how future biomedical research and relationships between researchers and communities might be enhanced to more fully realize the goals of inclusion for all populations.